Hazmat Disaster Preparedness Training Program (HDPTP)

PROGRAM SUMMARY/ABSTRACT
HAZMAT DISASTER PREPAREDNESS TRAINING PROGRAM
The Prevention, Preparedness, and Response (P2R) Consortium is comprised of dedicated experts in
safety disciplines critical to the nation's health and well-being. Guided by a shared vision – to reduce
work-related harm and improve disaster preparedness and response – and an external advisory board of
devoted and experienced professionals, the P2R Consortium serves as a resource for workers,
responders, and residents across the country with a targeted focus on the population of United States
Department of Health and Human Services Public Health Regions 5, 6, and 8. The objective of each
training course is (1) to reduce work-related harm and, therefore, is part of the Hazardous Waste Worker
Training Program, HWWTP, or (2) to improve disaster preparedness and response and, therefore, is part
of the HazMat Disaster Preparedness Training Program, HDPTP.
Building on past successes and using evidence-based techniques to identify high-risk industries and
communities, the Consortium's HDPTP projects an annual delivery of approximately 170 courses to
reach over 22,000 responders (including residents) for an impressive impact of more than 330,000 hours
of training. By delivering this training, the public health impact of the P2R Consortium is a knowledgeable
workforce and community with the skills and confidence to recognize and mitigate hazards, thereby
protecting health and well-being. Finally, as in the past, the P2R Consortium places special emphasis on
building the capacity of vulnerable communities to respond to environmental and work-related threats.